Robust Predictors of Mania and Psychosis

ADMINISTRATIVE SUPPLEMENT PROJECT SUMMARY:
This application is an administrative supplement in response to PA-20-272 for a year of extension
with funds. The major goals of the supplement are to 1) make data collected and tools developed
under the parent grant available to the wider scientific community, and 2) extend data collection
in a subset of participants whose data are deemed highly valuable. In Aim 1, we propose to curate
30 multimodal longitudinal (1-year long) datasets to the common format and ethical standard of
the National Institute of Mental Health data archive (NDA), including de-identification and
transcription of clinical interviews, for sharing with interested investigators in the Intensive
Longitudinal Health Behaviors Network (ILHBN) and the wider scientific commnunity. We will also
work to disseminate the Deep Phenotyping ToolKit developed under the parent grant, which
includes tools for the aggregation and quality control, interactive visualization, and processing of
multimodal longitudinal data. In Aim 2, we propose to study 10 select participants for longer than
the one-year period designated in the parent grant. The participants will be selected based on
having temporally dense multimodal data and fluctuating symptoms. To formalize the process of
participant selection, we will develop a tool for forecasting the value of a participant’s longitudinal
data, based on data missingness and variance in clinical scores in an initial study period.
While the Covid pandemic has had an impact on the parent project, this supplement proposal
goes far beyond simply compensating for adverse effects of the pandemic on productivity. The
extended goals of the supplement rely on the integration of data and accumulation of knowledge
afforded by the parent grant, and could not have been accomplished within the scope of the parent
grant. Overall, making multimodal longitudinal datasets, and tools to visualize and process
multimodal longitudinal data, available across and beyond the ILHBN community, will maximally
leverage the potential of these assets for a broad array of investigators nationally and globally,
and will foster the development of common standards for handling longitudinal data. Wider access
to high-quality, temporally-dense, behavioral and clinical data in individuals with a mental illness
will facilitate and accelerate rigorous computational phenotyping research of severe mental
states.

Public health relevance
PROJECT NARRATIVE The main goal of the parent grant “Robust predictors of mania and psychosis” is to identify biological, environmental, and social factors that trigger dangerous mental states, particularly mania and psychosis, in individuals known to be at risk for these conditions by acquiring high quality, temporally dense, longitudinal behavioral data, and using machine learning approaches to iteratively identify factors that increase or decrease the likelihood of these conditions. We focus on early psychosis (both affective and non-affective psychosis), which is a critical time period when there are fewer confounds such as prolonged medication exposure and chronicity, and when early intervention strategies will be most effective, prior to the progression that often leads to debilitating and chronic illnesses, to great suffering, and to an enormous public health problem and economic burden. By developing predictors for mania and psychosis from smartphone, wearable, and audio- video data and then testing these predictors over 100 person-years in individuals with active psychotic disorders, the data collected will make it possible to identify specific factors in the physical, social, and/or built environment that facilitate or hinder healthy behaviors in early psychosis and bipolar disorder and lay the groundwork for tailored intervention strategies that fully account for these factors to maximize efficacy at the individual level.